A Novel Platform to Identify and Treat Transitional Age Youth With Alcohol Use Disorder

Project Summary
This proposal seeks to determine the feasibility and acceptability of developing a data management
platform (DMP) tailored for researchers and health departments attempting to identify young adults with alcohol
use disorder (AUD) who are not enrolled in 4-year colleges. This is an urgent area of research; rates of alcohol
misuse peak among young adults. Due to convenience, most participant samples have involved young adults
enrolled in 4-year colleges. Research is urgently needed to identify young adults with AUD who are not
enrolled in 4-year colleges to provide them with potential interventions and reduce the health inequity of this
research.
Top technology companies, such as Facebook and Google, have become experts at developing DMPs that
target consumers relevant to a product who are statistically likely to click on advertisements and purchase the
product. For example, pharmaceutical companies can use a HIPAA-compliant DMP to identify mobile devices
owned by individuals statistically likely to have depression (i.e., “look-alike audience targeting) by referencing a
variety of health (e.g., pharmacy claims), digital behavior (e.g, websites visited) and demographic datasets to
help improve precisely when, how, and what type of depression medication or related advertisement to deliver
to each device to increase patient interest. However, to our knowledge, no DMP exists that can be used to help
identify individuals with AUD to increase their enrollment in research. This means that health departments and
researchers attempting to identify and enroll young adults with AUD need to either recruit in person (which is
time-consuming and lacks scalability) or through the use of Facebook and other broad traditional DMPs, which
is inefficient and not tailored (i.e., it wastes time and money paying for ads that will be shown to many people
without OUD). We seek to create (and evaluate the feasibility and acceptability of) the first DMP tailored for
researchers and health departments attempting to identify young adults with AUD who are not enrolled in 4-
year colleges. Through partnerships and preliminary research we have developed with industry advertising
partners during the COVID-19 pandemic, we will leverage our team’s experience and data from previous
NIDA-funded SBIRs to help substance use researchers, and a NIDA-funded R34 suggesting that patients
would find this approach acceptable. Beyond this Phase 1 application, this approach might later be scaled (and
tailored to almost all clinical conditions) to be the first known DMP for increasing enrollment of participants to
health-related research.

Public health relevance
Project Narrative There is a critical need to identify young adults who misuse alcohol and are not enrolled in four-year colleges to prevent and treat alcohol misuse, alcohol use disorder (AUD) and other alcohol-related consequences. Through a process called “look-alike audience targeting,” the advertising industry has been successfully using data and machine learning models to identify (and send outreach communications) to individuals that fit the statistical profile of a person likely to purchase a target product (e.g., shoes). This application seeks to leverage that approach, as well as our advertising industry relationships and preliminary research with them, and apply it to addressing the urgent public health problem of alcohol misuse among this understudied population.